Longitudinal study of health and functioning among adults with disabilities in All of Us

This project is being developed as a partnered research study in conjunction with the All of Us Research Program and Dr. Alison Cernich, Acting Director of NICHD. Work in FY25 has focused on development of the study proposal, addressing the compatibility of the WD-FAB software with the All of Us research platform, supporting Spanish translation of the WD-FAB, forming the Community Engagement Panel, performing analyses using existing All of Us data to inform future work, and conducting a literature scan on potential existing measures of assistive technology use, need, and impact that would best address the goals of the study.